PET STUDY OF CNS BENZODIAZEPINE RECEPTORS IN ADOLESCENT ONSET ALCOHOLISM

This study proposes to obtain pilot data on the effects of chronic and alcohol consumption on benzodiazepine receptor (BZR) distribution and density in adolescent onset alcohol dependence using [11C] flumazenil binding visualized by PET. Alterations in the gamma-aminobutyric acid (GABA) neurotransmitter system induced by chronic alcohol consumption represent the mostly likely neurochemical substrate of alcohol dependence. Subjects with adolescent-onset alcohol use disorders, compared with controls, will show reduced binding of [11C]-flumazenil in the cingulate cortex.